Integrin activation during neutrophil adhesion and vascular inflammation

Abstract
Neutrophils, which are essential for host defense against bacterial and fungal infections, induce inflammation
following tissue necrosis or ischemic injury. If not properly resolved, neutrophilic inflammation is the driving force
behind a plethora of human inflammatory diseases. Neutrophils, delivered via the bloodstream, arrive at the site
of injury by first rolling along the vessel wall and then arresting. Arrest is triggered by chemokines that induce
the high-affinity conformation of β2 integrins. Two FERM domain proteins, kindlin-3 and talin-1, are required for
neutrophil arrest. It is well known that talin-1, an adaptor protein that binds the actin cytoskeleton, activates
integrins by binding and altering the topology of the β transmembrane domain. We recently reported that kindlin-3
is recruited to the plasma membrane through its pleckstrin homology domain prior to neutrophil arrest. However,
the mechanism underlying neutrophil spreading and the role of kindlin-3 in this process are poorly understood.
Moreover, how kindlin-3 cooperates with talin-1 to activate integrins and whether kindlin-3 also functions as an
adaptor protein by directly binding to actin are completely unknown. Our overarching hypothesis is that, during
neutrophil spreading, both kindlin-3 and talin-1 are simultaneously recruited to the plasma membrane, where
kindlin-3 organizes high-affinity integrin activation. To test this hypothesis, we generated reporter mouse lines
for simultaneous detection of β2 integrin activation and imaging of kindlin-3 and talin-1 in mouse neutrophils. In
Aim 1, we will test the hypothesis that kindlin-3 organizes a ring of clustered high-affinity β2 integrins during
neutrophil spreading under flow conditions; in Aim 2, we will test the hypothesis that kindlin-3 regulates integrin
activation by directly binding to the actin cytoskeleton; and in Aim 3, we will determine the role of β2 integrin
activation in ischemia-reperfusion injury (IRI). The proposed research is conceptually innovative and highly
significant because it will resolve the enigma of how kindlin-3 organizes high-affinity integrin activation and define
the role it plays in IRI-induced inflammation. Successful completion of this proposal will establish molecular
mechanisms of integrin activation and provide mechanistic insight into neutrophil spreading and vascular
inflammation.
1

Public health relevance
Narrative Inflammation contributes to the pathogenesis of many leading causes of mortality, including heart disease and associated pathologies such as ischemia-reperfusion injury. Neutrophils adhere to the vessel wall through extracellular matrix interactions mediated by integrin and spread before migrating to sites of inflammation. It has been shown that manipulating neutrophil adhesion is beneficial in various pathological settings, including transplantation and inflammatory bowel diseases, among others. Here, we propose to investigate the fundamental integrin activation mechanism that drives neutrophil adhesion in inflammation. Completion of this study is expected to provide key insights into cell adhesion mechanisms and facilitate the development of novel drugs targeting inflammation. 2